Characterizing Alzheimer's disease molecular and anatomical imaging markers and their relationships with cognition and genetics using machine learning

Project Summary
Amyloid-beta and tau are hallmarks of mild cognitive impairment (MCI)/Alzheimer’s disease (AD). The
relationships of in-vivo amyloid-beta, tau, and neurodegeneration with cognitive, clinical, and genetic markers
are not well understood. Patients with AD pathology exhibit heterogeneity in their clinical symptoms and illness
course. Understanding the underlying neurobiological heterogeneity mechanisms of AD and improving the
outcomes have been the central goals. This proposal leverages complementary information of in-vivo amyloid-
beta positron emission tomography (amyloid PET), tau PET, structural magnetic resonance imaging (sMRI),
cognitive, clinical, and genetic measurements via advanced machine learning methods and investigates the
relationships among these measurements in patients with MCI/AD relative to normal controls. The proposal will
study the data from the Alzheimer Disease Neuroimaging Initiative (ADNI; N = 898) and the Washington
University’s Knight Alzheimer Disease Research Center (Knight ADRC; N = 1,121). This study will be the first to
examine regional amyloid PET, tau PET, and sMRI markers and their relationships with cognitive, clinical, and
genetic phenotypes using machine learning predictive modeling and heterogeneity analytics in AD research. The
proposal will quantify regional PET outcomes as distribution volume ratio (DVR) and sMRI as the volumes and
investigate their associations with cognitive [Mini-mental state examination (MMSE)], clinical [clinical dementia
rating sum of boxes (CDR-SB) and CDR], and genetic [polygenic risk scores (PRS) and apolipoprotein E (APOE)]
measurements. Aim 1 will develop machine learning modeling methods to study the relationships of amyloid
PET, tau PET, and sMRI with cognitive and clinical phenotypes and test the hypothesis of whether regional
brain-based imaging measurements exhibit multivariate predictive associations with cognitive and clinical
phenotypes in MCI/AD patients and controls. Aim 2 will study the regional heterogeneity of amyloid PET, tau
PET, and sMRI outcomes via semi-supervised machine learning methods. The study will compare the imaging
outcomes between identified subgroups of patients or controls vs. each subgroup of patients to test the
hypothesis of whether imaging markers differ between subgroups of patients. Aim 3 will examine the
relationships of amyloid PET, tau PET, and sMRI heterogeneity signatures with cognition and genetics to test
whether imaging signatures associate differentially with cognition and genetics in the subgroups of MCI/AD
relative to controls. Overall, this innovative proposal will yield critical information on AD heterogeneity
mechanisms, and contribute to precision medicine of diagnosis and treatment of AD.
1

Public health relevance
Project Narrative / Public Health Relevance This proposal aims to evaluate the relationships of brain PET and MRI markers with cognition and genetics in mild cognitive impairment/Alzheimer’s disease patients and normal controls. By leveraging complementary information of amyloid PET, tau PET, MRI, cognitive, clinical, and genetic markers via machine learning methods, this study will elucidate the first evidence on whether there are potential subgroups of patients relative to controls and show their differential relationships among these markers. Upon success, this will provide a rationale for designing larger-scale future studies and ultimately aid in precision medicine for the diagnosis and treatment of patients with Alzheimer’s disease. 1